Discovering and Exploiting Mechanisms of Neuroblastoma Therapy Resistance

OVERALL SUMMARY/ABSTRACT
This is a revised competitive renewal application for a Program focused on high-risk neuroblastoma (NB), a
diverse and enigmatic malignancy arising from the developing sympathetic nervous system that remains lethal
in 50% of patients despite intensive multi-modal therapy. The primary goal of this multi-institutional and multi-
disciplinary Program is to achieve improved outcomes for patients with high-risk NB by 1) discovering basic
mechanisms of de novo and acquired resistance to modern therapies; 2) uncovering targetable vulnerabilities
driving resistance; and 3) translating these insights into evidence-based clinical trials. The Program has been
productive, with important basic, translational, and clinical research achievements over the past 5.5 years. The
basic structure of the Program remains the same, with four Projects focusing on interrelated fundamental
problems in the broad fields of epigenomics, tumor microenvironment, and immuno-oncology. The central
hypothesis is that high-risk NBs evolve to evade therapeutic interventions but that these resistance
mechanisms can be targeted therapeutically. The motivation for the proposed research is the urgent need to
improve survival of patients with high-risk NB, and to decrease treatment-related morbidities. The four proposed
Projects will each address the three Specific Aims of the overall Program: 1) discover mechanisms of NB
therapy resistance; 2) discover tumor-intrinsic and -extrinsic therapeutic vulnerabilities imparted by therapy
resistance; and 3) develop readily translatable therapeutic strategies to exploit de novo and acquired
resistance mechanisms and molecular vulnerabilities. The Projects will each be supported by two Cores: A)
Administrative core; B) Translational, statistical, and clinical trials core. Unique to the Program is the New
Approaches to NB Therapy (NANT) consortium integrated into Core B now in its 22nd year. A major goal of the
NANT is to prioritize new therapies from our Projects for Phase 1 and 2 clinical trials in the high-risk NB relapse
population, with the goal of moving these to Phase 3 testing in newly diagnosed patients. The Program is
responsible for the two targeted investigational agents currently being tested in an ongoing Children’s
Oncology Group Phase 3 trial. The NANT also provides a unique resource of therapy resistant tumors and
other biospecimens for Project investigators. Importantly, all Projects have clear milestones to deliver one or
more clinical trial to the NANT, with Project specific studies designed to provide the portfolio of nonclinical data
required for efficient translation to the refractory NB patient population. This highly integrated Program
proposes a variety of innovative experimental strategies to uncover basic mechanisms of oncogenesis and
therapy resistance, but is steadfastly translational, as the investigative team is constituted of physicians who
care for children with this disease. The significance of the proposed Program is the continued discovery of
fundamental mechanisms of cancer therapy resistance leading to substantively improved probability of cure
coupled with reduced therapy-related morbidity for children, adolescents and adults afflicted with high-risk NB.

Public health relevance
OVERALL NARRATIVE The proposed Program is relevant to public health because it seeks to discover fundamental principles of cancer etiology, evolution, and evasion of response to therapy, focusing on the childhood malignancy neuroblastoma. The research is highly relevant to the NIH mission and the urgent unmet need of developing rational evidence- based therapeutic strategies to reduce the health burden of cancer. This integrated multi-disciplinary Program is designed to continue to catalyze improved cure rates with decreased morbidity for patients with high-risk neuroblastoma, and many advances will be applicable to the field of cancer in general.